Administrative Core

ABSTRACT / PROJECT SUMMARY
Administrative Core
The purpose of the UCLA, “Acne Center of Research Translation (CORT)”, is to engage investigators in
translational research in skin disease. The overall goal of the UCLA Acne CORT Administrative Core is to both
foster collaborative research within the CORT and facilitate productive interactions at UCLA and with the
CORT advisory group. Dr. Robert Modlin, Center of Research Translation Director, will be the Leader of the
Administrative Core, with support from Dr. Richard Gallo, the Center of Research Translation Associate
Director. This Core will enable all of the scientific components of the CORT to interact by providing the
structure and financial support for regular planning, sharing, and evaluation of the research. The Admin Core
will be responsible for ensuring that the investigators act as a cohesive and interactive group to achieve
synergy in their research efforts. The goals of the Admin Core are to: 1) engage investigators from different
areas of expertise in translational research into the relationship between the microbiome and the host immune
response in skin; 2) facilitate interaction with Acne CORT scientists, the Executive Steering Committee, and
the Advisory Committee; 3) oversee the finances and budgeting of the CORT, prepare reports and manage
administrative Acne CORT personnel; 4) promote communications and collaborations between the scientists
within the CORT and across UCLA and UCSD campuses, in investigating acne and understanding the
mechanisms by which the microbiome and the host immune response interact, and with younger investigators,
emphasizing underrepresented populations in the research field; 5) solicit and review Pilot and Feasibility
projects to support exploratory studies related to acne, to increase the number of investigators in the field; and
6) provide leadership, organization and inter-institutional integration for the Enrichment Program.